A translational evaluation of depressive symptomology and smoking cessation treatment mechanisms for just-in-time-adaptive-interventions

PROJECT ABSTRACT
Adults with current major depression are twice as likely to smoke cigarettes and less likely to quit versus those
with no psychiatric diagnosis, even with evidence-based treatment. To improve smoking cessation treatment
efficacy, it is critical to 1) identify how treatment mechanisms vary between adults with and without elevated
depressive symptoms and 2) examine how transdiagnostic depressive and smoking abstinence symptoms
interfere with treatment. However, smoking cessation trials typically exclude participants with psychopathology
or rely exclusively on limited assessments of depression (e.g., binary status: current vs. never depressed, self-
reported affect). Transdiagnostic processes implicated in depression, including atypical motivation to positive
and aversive contexts (positive/negative valence systems; PVS/NVS), may be central to smoking behavior, but
are typically not evaluated and their utility for predicting smoking behavior compared to categorical depression
status has rarely been assessed. Just-in-time adaptive interventions (JITAIs) can enable examination of
momentary treatment processes among individuals with depressive symptoms who may experience
motivational deficits because they are low burden, highly accessible, and can harness ecological momentary
assessments (EMA) to monitor and immediately intervene on key treatment and relapse processes across the
quit attempt. The goals of this K23 proposal are 1) to evaluate JITAI treatment mechanisms for smoking
cessation in adults with and without elevated depressive symptoms and 2) examine attenuation of treatment
efficacy and mechanisms associated with disrupted PVS and NVS processes. Aim 1 of the project will evaluate
the role of depressive symptoms on smoking cessation and treatment mechanisms using secondary data from
a large JITAI randomized controlled trial (RCT). This aim will use moderated mediation models to evaluate
group differences in treatment mechanisms. Aim 2 will collect original data to examine changes in PVS and
NVS processes during a JITAI RCT using a translational, multimethod approach with EMA, behavioral, and
psychophysiological data to identify the transdiagnostic processes that attenuate treatment effects and prevent
cessation among adults with elevated depressive symptoms. This aim will collect PVS and NVS assessments
across two laboratory visits and 13-weeks of EMA. The proposed research will identify the processes that
contribute to reduced treatment efficacy for smoking cessation interventions among adults with elevated
depressive symptoms. Long term, this work will allow for the development of novel and/or adjunct interventions
to counteract biopsychosocial processes that reduce treatment efficacy among adults with psychopathology
who smoke. Additionally, the expertise gained from the proposed training plan in multimethod, translational
methodology can be extended to other high priority populations (e.g., low income, minoritized individuals) that
experience the greatest health disparities from smoking and may benefit less from available interventions.

Public health relevance
PROJECT NARRATIVE Individuals with depressive disorders experience higher health burden and mortality from smoking-related illness and are less likely to quit smoking with treatment. This K23 proposal will evaluate the processes that may make smoking treatments less effective for individuals with elevated depressive symptoms using a highly accessible mHealth intervention. This work will inform the development of novel interventions to target these processes and improve smoking treatment among individuals with depressive disorders.